Program in Molecular Biophysics

Project Summary
The Program in Molecular Biophysics (PMB) is a PhD training program at the Johns
Hopkins University (JHU) spanning 4 schools and 12 primary departments. The focus is on the
physical-chemical and structural basis of life sciences, spanning from single-molecules to
enormous macromolecular complexes and cellular systems. Experiment and computation are
equally represented and closely intertwined, providing rigorous training in quantitative and
physical approaches to life sciences. The 30 training investigators run labs that are well funded
and of moderate size, providing ample resources for research and student support and close and
carefully monitored trainee mentorship.
Students are selected from a highly qualified pool of applicants using holistic admissions
criteria, including dedication to science, research background, and perseverance, in addition to
quantitative metrics. Through substantial efforts to encourage applications from URM students
and assistance from a strong institutional diversity program, the PMB recruits a highly diverse and
talented cohort of trainees. Each year, eight students matriculate and are supported for two years
by the grant with stipend and tuition supplements provided by JHU. First year coursework is
designed specifically for PMB trainees using active-learning techniques, such as recently
designed Methods and Computational Modules, in which graduate-level theoretical instruction is
directly linked to actual data collection and analysis. Other courses include fundamental aspects
of biomolecules, scientific computing, statistics, data analysis, and reproducibility. From the
beginning, soft-skill and career development are integrated in the curriculum. Through PMB
career development activities along with JHU resources, these skills help propel graduates to
advanced positions in diverse biomedical science. Instruction and promotion of responsible
conduct of research is interwoven throughout the entire training program.
Progress with independent research is carefully monitored through internal committee
assessment, as well as external mentor assessment. Through a mentoring mechanism that
provides early guidance transitioning to independence, trainees perform high impact thesis
research, historically resulting in a large number of publications, talks, and advanced positions
following graduation. The activities of the PMB are designed to contribute to fundamental scientific
research and train responsible scientists who will become leaders in the biomedical workforce.

Public health relevance
Project Narrative The grand challenge in the life sciences during the 21st century is understanding how all molecules of life interact, working in concert to give rise to the living state, normal and diseased. Molecular biophysics is the interdisciplinary field that will provide this understanding. The Program in Molecular Biophysics trains predoctoral researchers to solve biomedical problems from first principles.